Postsynaptic roles of ankyrins

ABSTRACT
Extensive evidence implicates glutamatergic synapses as key pathogenic sites in neuropsychiatric disorders
(NPDs). Recently-emerging evidence has implicated ankyrin proteins, including Ankyrin-G (AnkG),
encoded by the ANK3 gene, and Ankyrin-B (AnkB), encoded by ANK2, in the biology of central nervous
system synapses. While conventionally AnkG and –B have been seen as playing roles mainly at the axon
initial segment, their functions in central glutamatergic synapses have only begun to be investigated,
including in studies initiated by our laboratory. During the previous funding period, we have made extensive
progress in understanding the regulation and interactome of AnkG at synapses and in dendrites. Our
preliminary findings broaden our understanding of the neurobiology of ankyrins, and implicate them in
several novel process, including deubiquitination and endocannabinoid signaling. In this proposal we will
use neuroproteomics, conditional knockout and reporter mice, super-resolution and in vivo two-photon
microscopy, calcium imaging, bioinformatics, and behavioral analyses, to investigate the functions of
AnkG's protein partners in dendrite and at glutamatergic synapses. We hypothesize that AnkG performs
multiple novel functions including supramolecular scaffold complex maintenance and regulation of
endocannabinoid signaling, through which it controls spiny synapse development, structure, function, as
well as circuit level network activity and behavior, in a cell type and developmental period-specific manner.
We will test this hypothesis in the following Aims: Aim 1. To investigate the impact of cell type-dependent
and developmentally-timed knock out of AnkG on brain structure, function, and behavior across
maturation. Aim 2. To investigate the impact of cell type-dependent and developmentally-timed knock out
of AnkB on brain structure, function, and behavior across maturation. Aim 3. To determine the mechanisms
and functional significance of the interaction of AnkG with DAGLĮ. The proposed studies are highly novel
and impactful, given that the synaptic functions of ankyrins are only beginning to be investigated. This
proposal will be the first to investigate the function of several recently-discovered AnkG-interacting proteins
in unexpected biological processes, using multiple cutting edge methods, and will open new avenues for
many future studies.

Public health relevance
NARRATIVE While conventionally seen as restricted to axon initial segments, recent evidence has implicated Ankyrin-G and Ankyrin-B in the biology of central nervous system glutamatergic synapses. However, little is known about their postsynaptic roles. Here, building on our progress made during the previous funding period, we will investigate the functions of ankyrins and their protein partners at cortical glutamatergic synapses, cortical circuits, and behaviors controlled by the frontal cortex.